Admin Core - Functional genomics resources for the Drosophila

PROJECT SUMMARY – ADMINISTRATION & MANAGEMENT
Our current leadership group has a combined 35 years of experience working together to oversee a successful
community-focused research technology facility. The Drosophila Research Screening Center-Biomedical
Technology Research Resource (DRSC-BTRR) will build on this success, placing our leadership team
members in positions that make the most of their experience and expertise, and assessing potential new
collaborations and technologies in a define and consistent manner. Together with an executive advisory
committee (EAC), as well as ad hoc meetings of a local steering committee, the DRSC-BTRR leaders will
establish user agreements and policies; ensure proper oversight and integration of each component of the
resource; and maintain open communication with existing and potential new collaborators. Moreover, we will
add new collaborations and technologies when they fit well with existing technologies, are feasible, have
potential for high impact, and, for biomedical projects, when they further balance our portfolio. We will also
work towards the goal of sustainable access to the technologies we develop, including by maintaining our well-
established pipelines for sharing of fly stocks, plasmids, cell lines, and other reagents with appropriate
distribution facilities.